Prevention Research Center: Parenting Among Women Who Are Opioid Users

PROJECT SUMMARY
The global SARS-CoV-2 pandemic that causes the severe respiratory illness COVID-19 is the worst health
crisis the United States has faced in a century. Although this highly contagious virus has infected millions of
Americans already, the disease burdens are disproportionately born by historically underserved populations
such as Latinx communities. Nationally, Latinx people with COVID-19 are hospitalized at four times the rate of
Whites and have much higher rates of morbidity and mortality. This disparity is notable in Oregon, where the
13% of our population that is Latinx represents approximately 44% of COVID-19 cases. An urgent need exists
to reach Oregon’s Latinx community with public health and prevention messages to increase testing. This
project will implement a culturally-tailored community outreach and testing program to increase the reach,
access, and uptake of testing in Latinx communities in Oregon. The project will bring together a world-class
team of prevention scientists, public health experts, Latinx researchers, community partners, and biologists
who have been working together to conduct SARS-CoV-2 diagnostic testing since March, soon after the
pandemic first arrived in the U.S. This team has established a CLIA-certified laboratory and honed molecular
testing protocols, hired and trained laboratory personnel and a field research team, procured diagnostic testing
equipment and supplies, and partnered with county public health offices and hospitals throughout the state to
conduct testing. The team also conducted a comprehensive community assessment using community-based
participatory methods to gather Latinx community feedback on modes of communication, health messages,
and testing protocols, and staffed multiple county-led testing sites serving Latinx communities. Using these
resources and expertise as a foundation, a Sequential Multiple Armed Randomized Trial (SMART) will enable
the evaluation of strategies for increasing testing rates and promoting health behaviors in Latinx communities.
Specifically, culturally informed, community-oriented interventions will determine tools and best practices to
increase testing rates and health behaviors. The efficacy of different types of approaches for increasing access
to and utilization of testing will be evaluated. Lastly, the work will examine a set of county-level variables
thought to affect communities’ abilities to sustain testing capacity. With support from a Latinx Community and
Scientific Advisory Board, the project will ramp up to ultimately support 36 community testing sites across six
counties in Oregon to serve Latinx communities. Over time, this project will help communities institutionalize
optimal local testing frameworks supported by UO laboratory facilities for testing capacity, technical support for
testing logistics, and collection of data on health behaviors, testing rates, and sustainability. The resulting
structures and systems will be poised for future scale-up to other vulnerable communities and/or for other
public health purposes (e.g., vaccination campaigns). If successful, this project will lead to a major reduction in
COVID-19 health disparities in underserved populations.

Public health relevance
PROJECT NARRATIVE The global SARS-CoV-2 pandemic represents the worst public health crisis faced by the United States in a century, with a disproportionate burden of disease and mortality experienced by vulnerable and historically underserved populations. The proposed project addresses the significant disparities in COVID-19 cases among underserved Latinx populations in Oregon by collaborating with community partners to scale up 36 testing sites across 6 counties through implementation of a SMART trial incorporating culturally tailored health interventions to improve reach, access, and uptake of testing among Latinx communities. By leveraging expertise in prevention science, genomics, and community-based participatory research, this project will support community partners in implementing and sustaining structures and systems for COVID-19 testing and health promotion activities that can be leveraged to serve other vulnerable communities or for related public health efforts, such as vaccination campaigns.